A patient-specific hiPSC model of breast cancer to identify genetic determinants of subclonal response and resistance to PARP inhibitors

PROJECT SUMMARY
Breast cancer is the most common cancer among women worldwide, affecting one in eight women in
the United States during their lifetime. Existing patient-derived models for breast cancer, including cell and
organoid cultures and patient-derived xenografts, fail to recapitulate important aspects of breast tumorigenesis.
Notably, these models are derived from late-stage tumors, undergo genetic drift and selection in culture, and are
incompatible with high-throughput genetic and chemical screening. There is a clear need for more robust
preclinical models of breast cancer that enhance translation of basic cancer research into meaningful
improvements in patient outcomes. Human induced pluripotent stem cells (hiPSCs) are an appealing tool for
modeling breast cancer because they provide a scalable source of patient-derived cells that retain molecular
features of underlying cancer cells, including mutational burdens and drug sensitives. Additionally, as hiPSCs
are clonally derived from single cells, multiple hiPSC lines from an individual tumor provide a tool to examine
subclone-specific contributions to tumorigenesis and therapy response. However, no study to-date has examined
the potential of hiPSCs to model breast tumorigenesis. This study aims to develop a novel preclinical model
of breast cancer by generating hiPSC lines from human breast tumors and to use this model to examine
patient and subclone-specific responses to poly (ADP-ribose) polymerase (PARP) inhibitors. PARP
inhibitors target intrinsic DNA damage repair deficiencies in tumor cells and are a promising therapeutic for
subsets of highly aggressive, BRCA-mutant triple negative breast cancers. In Aim 1, we will reprogram primary
breast cancer cells to an hiPSC state, followed by differentiation into mammary epithelial cells (MECs) for in vitro
disease modeling. We will use in-depth sequencing to determine the extent to which the genetic heterogeneity
of hiPSC lines recapitulates the clonal heterogeneity of primary tumors. In Aim 2, we will use genetically distinct
hiPSC-MEC lines derived from a BRCA mutant breast tumor to examine subclonal differences in DNA damage
repair proficiency, intrinsic sensitivity to PARP inhibitors, and propensity to acquire PARP inhibitor resistance.
Subclone-specific mechanisms of PARP inhibitor resistance will be mechanistically validated using gene editing
in this model. Completion of these aims will fill a critical need for novel in vitro models of breast cancer that
accurately capture the genomic heterogeneity of human breast tumors and can be used to model how patient-
specific subclonal tumor architecture influences response to therapy. Additionally, the proposed project provides
a platform for the applicant’s predoctoral training, with a focus on developing expertise in cancer disease
modeling and precision oncology, skills related to experimental design and analysis, proficiency in computational
pharmacogenomics, and the professional skills required to pursue a career in translational cancer research.

Public health relevance
PROJECT NARRATIVE Breast cancer is the most common cancer among women in the United States, and resistance to systemic and targeted therapies is a primary contributor to disease mortality. There is a clear need for enhanced preclinical models of breast cancer that capture patient-specific cancer genomes to identify and validate predictive pharmacogenomic biomarkers for therapy response. This research will provide a novel in vitro model of breast cancer that recapitulates the genomic heterogeneity of human breast tumors, providing a powerful platform for preclinical genetic and therapeutic screening to inform precision oncology.